Administrative Core

Project summary (Admin Core)
The Administrative Core of the NYU BCC EDRN will provide leadership by establishing and maintaining the
infrastructure, organization, coordination, and fiscal management necessary to successfully complete the tasks
proposed within this application in the proposed timeframe, namely to develop and establish highly predictive
biomarkers via a throughput approach that can be standardized into a CLIA level assay. The Administrative Core
will ensure bidirectional exchange of findings and insights with other BCCs and CVCs, will work with the EDRN
DMCC to provide logistical and organizational support needed for data integration, and ensure participation in
collaborative projects with other laboratories and centers. In order to accomplish these general goals for this
BCC application we will provide administrative support for NYU BCC EDRN activities (Aim 1), coordinate NYU
BCC EDRN efforts integrating BDL with BRL (Aim 2) and facilitate evaluation and planning of NYU BCC EDRN
activities (Aim 3). The administrative core will be led by Dr. Leopoldo Segal (contact PI of this application) and
will include mPIs, Dr. Harvey Pass. In addition, the Admin core will designate Dr. Jun-Chieh (James) Tsay as
NYU EDRN Administrator, and Ms. Lira Gutierrez, Administrative Assistant. The main focus of the Admin Core
will include to provide fiscal management for the projects, prepare and file regulatory documents/progress
reports, coordinate BDL-BRL interactions as well as interactions with the Perlmutter Cancer Center, monitor
progress in each component of this BCC and identify new projects with translational impact as well as facilitate
junior faculty development.